Dissecting the circuits and population dynamics that represent unconditioned and conditioned stimuli in the ventral hippocampus

Project Summary
Neural population dynamics are in constant flux, with patterns of activity across neurons being updated to
account for changes in the relationships between important stimuli in the environment. Recent work from our
group has shown that ensembles of CA1 neurons can represent the associations between stimuli and their
outcomes, multiplexing stimulus and outcome representations into a format that is stored for days. However, the
circuit mechanisms by which the ventral hippocampus performs these computations remains unknown. In this
proposal we will leverage anatomical targeting of discrete cell classes, large-scale population recording,
computational tools, and cell-type specific manipulation to understand how classes of ventral CA1 neuron
acquire, update and store information during associative learning. In Aim 1 we will understand how vCA1
neurons that project to the nucleus accumbens, amygdala and/or mPFC acquire responses to conditioned and
unconditioned cues through learning. In Aim 2 we will determine how these classes of neurons flexibly change
their responses with switches in stimulus or outcome valences. In Aim 3 we will ask if information related to
conditioned and unconditioned stimuli converge in vCA1 and how this process facilitates acquisition and storage
of associative memories. Understanding these basic principles of vCA1 encoding properties will be crucial to
efforts to understand the circuit mechanisms that contribute cognitive and emotional disorders with underlying
dysfunction in associative learning processes.

Public health relevance
Project Narrative This work will examine the substrates for reward and aversive learning. Understanding these processes will provide insight into how brain circuit dysfunction may contribute to mood and cognitive disorders characterized by overgeneralization of memory.